Modulation of Inflammation and Oxidative Stress in Diabetic Wound Healing

PROJECT SUMMARY/ABSTRACT: The diabetic wound healing impairment represents a major clinical
problem, resulting in prolonged hospitalizations and significant healthcare expenditures. Two-thirds of non-
traumatic amputations are preceded by a diabetic wound. The impaired healing of diabetic wounds has been
shown to be multifactorial, however, increasing evidence suggests that persistent inflammation contributes to
the pathogenesis of diabetic wounds through persistent activation of inflammatory pathways and increased
oxidative stress. We have shown that diabetic wounds have increased expression of the proinflammatory
cytokines IL-6 and IL-8, and decreased expression of the anti-inflammatory microRNA-146a, which inhibits
NFkB activation and downstream IL-6 and IL-8 gene expression. In normal wound healing, macrophages are
initially polarized to the proinflammatory M1 phenotype and then transition to the M2 phenotype, which is
associated with resolution of inflammation and wound closure. Chronic inflammation and the associated ROS
promote persistent proinflammatory M1 macrophage polarization and a failure to transition to the M2
phenotype, which has been implicated in the development of chronic diabetic wounds. We have designed
novel cerium oxide nanoparticles (CNPs) that possess ROS scavenging properties and have conjugated them
with a miR-146a mimetic, to synergistically target both proinflammatory signaling and ROS. In compelling
preliminary data, we have found that one-time treatment of murine diabetic wounds with our novel miR-146a
conjugated CNPs (CNP-miR146a) can improve diabetic wound healing, similar to that of non-diabetic wounds
at 7 days, and this is associated with decreased inflammation and decreased expression of NOX2. In
additional preliminary data, we have shown that CNP-miR146a can also improve wound healing in a
streptozotocin porcine diabetes model. The objective of this work is to determine the mechanisms by which
CNP-miR146a corrects the diabetic wound healing impairment, and validate this correction and toxicity in a
preclinical porcine model. We hypothesize that CNP-miR146a will reduce inflammation and oxidative stress,
thus driving macrophage transition from a proinflammatory (M1) to an anti-inflammatory (M2) phenotype and
allow for resolution of the chronic inflammatory response and result in enhanced healing.
Specific aim 1: To test whether CNP-miR146a corrects the diabetic wound healing impairment by
decreasing inflammation and oxidative stress.
Specific aim 2: To test whether decreased inflammation and oxidative stress with CNP-miR146a
treatment improves healing by decreased proinflammatory (M1) and increased anti-
inflammatory/resolving (M2) macrophage polarization.
Specific aim 3: To validate that microRNA-146a conjugated CNPs correct the diabetic wound healing
impairment and is non-toxic in a preclinical porcine model.

Public health relevance
PROJECT NARRATIVE Chronic inflammation, increased oxidative stress, and a failure to transition from a proinflammatory to anti- inflammatory macrophage phenotype have been implicated as major components of the pathogenesis of the diabetic wound healing impairment. We have developed a novel strategy and data to support targeting inflammation and oxidative stress using an ROS scavenging cerium nanoparticle conjugated to the anti- inflammatory microRNA-146a to decrease oxidative stress and promote a transition from a proinflammatory to an anti-inflammatory macrophage phenotype to improve healing. Our overall goal is to determine the mechanisms of this correction, including the effect on inflammation, oxidative stress, and macrophage phenotype, and validate this correction and examine toxicity and pharmacokinetics in a preclinical porcine model of diabetes.